Correcting the Cellular Ecology of Diabetic Complications

PROJECT SUMMARY / ABSTRACT
Diabetes affects nearly 10% of the adult population (30 million), and these numbers are expected to double by
the year 2050. The pathophysiology of diabetes profoundly impairs all tissue reparative processes, leading to
chronic non-healing wounds in affected patients. Diabetic foot ulcers affect between 15-30% of all diabetic
individuals and represent the leading cause of lower limb amputations in the United States. Conventional
methods to treat diabetes, such as with insulin or oral hypoglycemic agents, can control the disease but do not
prevent diabetic complications, as demonstrated by continued progressive organ dysfunction even decades after
medical optimization. This highlights a clear need for new therapeutic approaches. Over the past 15 years of
NIH funding, our laboratory has made important contributions to our understanding of the critical molecular and
cellular pathways in normal and diabetic tissue repair. We have identified hyperglycemia-related impairments in
both the local microenvironment and progenitor cell homing and cytokine production that contribute to the
pathogenesis of diabetic complications. We have demonstrated that diabetes results in depletion of critical cell
subpopulations, resulting in decreased neovascularization and impaired tissue healing. To understand the
effects of diabetes on cell population dynamics with greater precision, we have developed novel single cell
“-omics” techniques to identify critical perturbations in cell subpopulations at the single cell level. It is our
fundamental hypothesis that diabetes alters the “cellular ecology” of heterogeneous cell populations involved
in tissue repair and that normalization of those cell subpopulations can treat or reverse diabetic complications.
In this proposal, we will integrate emerging multimodal -omics technologies to definitively characterize the
behavior of cell subpopulations in diabetic complications, including wound healing. We will extend this work
therapeutically by using cell-based approaches to normalize these defects to treat and prevent diabetic
complications. To begin, we will employ a novel multiplex approach for high-throughput single cell sequencing
to definitively characterize the behavior of resident tissue and progenitor cell subpopulations in human diabetic
and non-diabetic wounds (Specific Aim 1). We will then confirm these human observations in animal models and
define these changes with spatial resolution by integrating single cell sequencing with next-generation spatial
transcriptomic and proteomic technologies and precisely delineate where in the three-dimensional wound
environment these differences exist (Specific Aim 2). Finally, we will use this information to optimize the systemic
delivery of cell-based therapeutics in order to prevent or reverse diabetes-induced defects in relevant cell
populations and thereby correct diabetic complications (Specific Aim 3). Taken together, this novel approach for
identifying, spatially characterizing, and correcting subpopulation deficits in diabetic complications will provide
new insights into diabetic pathophysiology and inform novel strategies to prevent and treat these complications.

Public health relevance
NARRATIVE Wound healing is markedly impaired by diabetes, which is caused in part by alterations in the subpopulations of cells important for tissue repair. It is our fundamental hypothesis that restoration of those cellular populations can reverse these defects and correct wound healing and other diabetic complications. In this proposal, we will use emerging single cell techniques to identify the critical alterations in cellular populations induced by diabetes in mice and humans and use these insights to develop cell based strategies to restore these depleted populations to prevent diabetic complications.